Impact of estrogen replacement therapy on bone health in an aging population of women living with HIV

PROJECT SUMMARY / ABSTRACT
Current antiretroviral therapy (ART) regimens have rendered HIV a manageable chronic condition rather than a
fatal disease, with people who initiate ART soon after infection achieving nearly normal life expectancy. As a
consequence of increased survival, more women living with HIV (WLWH) will now undergo menopause and be
subject to a disease burden that reflects age along with adverse skeletal consequences of postmenopausal
estrogen deficiency. In addition to known bone loss and increased fracture risk in postmenopausal women, ART
also causes negative impacts on bone. Therefore ART-suppressed WLWH may have a compounded detrimental
effect on bone due to long-term ART treatment combined with menopause. We hypothesize that treatment with
estrogen replacement will attenuate the increased rate of bone loss during menopause and improve bone health
even with congruent administration of ART. We will address this hypothesis using a previously NIH-funded
project that employs a novel non-human primate model that replicates the sequence of acute infection, ART
initiation, chronic suppressed infection, and subsequent menopause now characteristic of a growing proportion
of aging WLWH. We intend to measure the impact of ART-suppression and menopause, with and without
hormone replacement therapy, on bone architecture and quality. Furthermore, we will determine whether bone
marrow, a known HIV reservoir, is deficient in necessary bone cell precursors. In conclusion, these studies will
examine bone health in an aging population of WLWH and potentially inform future care options utilizing hormone
replacement therapy to protect these women from compounded risk of bone fractures and osteoporosis.

Public health relevance
PROJECT NARRATIVE Due to the effectiveness of antiretroviral therapy (ART), there is an increase in women living with HIV (WLWH) who are aging and will undergo menopause. We intend to measure the impact of i) simian immunodeficiency virus (SIV) infection ii) ART-suppression iii) menopause and iv) presence or absence of hormone replacement therapy (HRT), on bone architecture and quality in a unique nonhuman primate model. These studies will focus on compound bone loss, bone health and fracture risk in our model of postmenopausal WLWH-with and without HRT and our results could inform future care options to protect these women from compounded risk of bone fractures and osteoporosis.